Illuminating Proximal Relational Dynamics to Enhance Initial Recovery from Alcohol Use Disorder

PROJECT SUMMARY/ABSTRACT
The goals of this Mentored Patient-Oriented Research Career Development Award are two-fold: (1) evaluate the
feasibility, acceptability, and preliminary clinical utility of measuring dyadic relational processes during early
recovery from alcohol use disorder (AUD) using ecological momentary assessment (EMA) to identify novel
proximal dynamics influencing early recovery outcomes and inform intervention designs targeting relational
mechanisms in both patients and romantic partners, and (2) establish the principal investigator as an
independent researcher at Massachusetts General Hospital-Harvard Medical School. The specific aims of this
research will be accomplished through an innovative study leveraging the strengths of dyadic ecological
momentary assessment and qualitative interviewing to collect interpersonal dynamics data within couples during
initial recovery. This research will serve as the methodological foundation for future studies illuminating relational
dynamics between people in recovery and close supportive others to understand how the proximal social context
impacts recovery outcomes. Further, this innovative study will inform interpersonal treatment approaches and
will characterize the cycle of shame and intentional withholding of information in initial recovery. Aims of the
principal investigator’s career development and training plan include: (1) Extend expertise in etiology of addiction
to recovery science; (2) Cultivate independent skills in social processes, couples’ interactions, and dyadic
momentary data collection and data analysis; (3) Develop expertise in qualitative research; and (4) Foster
transition from mentored postdoctoral training to independent translational clinical scientist. These goals will be
achieved through an interactive training plan comprised of mentorship, formal coursework, seminars,
conferences, and manuscript preparation. Knowledge gained via the training plan will be augmented and
enhanced through research endeavors planned throughout the funding period. Drs. John Kelly, Jaye Derrick,
Aidan Wright, and Christina Psaros will serve as mentors on this award, and will provide expertise in couples
interactions, dyadic processes and dyadic ecological momentary assessment, dyadic analytic approaches,
qualitative measurement, and addiction recovery science. Massachusetts General Hospital-Harvard Medical
School provides an exceptional environment in which to conduct research and launch a career as an independent
scientist engaged in alcohol use disorder treatment development. By the end of the 5-year award period, the
goals are to validate an interpersonally-focused ecological momentary assessment battery to be used in a larger
study of early recovery with key supports beyond romantic partners in the context of an R01, to accumulate initial
content necessary for an R34 submission to create just-in-time interventions for couples experiencing an initial
recovery attempt, and for the PI to be established as an independent investigator. This award is consistent with
NIAAA’s 2024-2028 strategic plan to explore the behavioral, environmental, and social mechanisms that impact
recovery outcomes to advance research on recovery from AUD (Goal 4, Objective 3).

Public health relevance
PROJECT NARRATIVE Alcohol use disorder is accompanied by significant individual and societal costs, and, despite established evidence-based care, return to alcohol use during initial recovery is common, highlighting the need to understand novel, malleable factors modulating early recovery success to improve recovery outcomes. Recovery is marked by shifts from substance-using to substance-free peers; yet the nature of discrete interpersonal interactions, particularly with close supports such as romantic partners, are likely to modulate recovery outcomes, with critical or unsupportive interactions serving as barriers in early recovery. This project will use dyadic ecological momentary assessment (EMA) during initial recovery to illuminate proximal relational dynamics modulating recovery success to inform novel interventions for people in recovery and romantic partners.